Administrative Supplement to Deciphering dopaminergic circuits required for food anticipatory activity in mice

Project Summary/Abstract
Given the over-abundance of food in modern society, it is easy to lose sight of the importance of
feeding to animals in nature. For most animals, food is extremely scarce and being wise to
opportunities to eat is essential for survival. As such, the circadian system has evolved to
receive a number of different stimuli—i.e., light, temperature, food, and even fear—to keep
biological processes coordinated and allow for adaptation to ever changing conditions. The
ability to tell time relative to feeding has a long history of research, going back more than one
hundred years hundred years with behavioral observations of honeybees and rats. However, the
neural circuitry behind adaptation of behavior to timed feeding has continually escaped our
grasp. In this project, I will utilize conditional genetics, viral restorations, and chemogenetic tools
to identify the dopamine population (both anatomically and genetically) that is required for the
behavioral expression of food anticipatory activity in lab mice. From here, we will build out a
more comprehensive characterization of how a select population of dopamine neurons
projecting to the striatum can inform the time keeping systems of the brain that food is available.

Public health relevance
Project Narrative Not applicable. This is an application for Administrative Supplement, per Notice Number NOT-GM-24-021. Per PA-20-272, forms must be completed for the supplemental activities only and must not reflect funding or activities for previously awarded parent award. There is no change from information submitted and approved for the existing awarded Parent Grant R16GM145576.